Dental Compression Analysis Using Confined Compression and Imagining

SUMMARY
Our preliminary data indicated that aging a restorative dental composite in an esterase
enzyme in artificial saliva (AS) resulted in a significant decrease in diametral strength relative to
specimens aged water with or without an acid. Building on this data, this research will utilize a
dentin ring containing a composite specimen to the structural integrity of dentin-adhesive and
adhesive-composite interfaces subjected to simulated oral environments with two model oral
bacteria (cariogenic S. mutans and S. sanguinis) and incubation in the presence of esterase
enzyme in AS media. In addition, the specimens will be subjected to axial and radial cyclic
loading within this dentin-adhesive-composite ring to simulate a class I restoration. Experiments
with the two Streptococcus strains will allow us to determine whether cariogenic incubation
conditions and/or biofilm growth and expression of glucsoyltransferases (gtfB, a key enzyme in
the production of extracellular matrix formation in cariogenic biofilms) significantly impact the
structural integrity of the test specimens. Inclusion of esterases will allow us to test whether
these enzymes degrade and reduce the strength of dentin-adhesive-composite bonds, as we
have shown previously with composites. Static tests will determine the role aqueous
geochemical conditions (either abiotic or biotically-induced) play in attacking the structural
integrity of the test specimens, and dynamically cycled compression will allow us to determine
the impact of simulated forces from mastication to more realistically model stress in vivo.
Analysis of the degradation products leaching from the interfaces and bulk composite will be
quantitatively characterized by Inductively Coupled Plasma-Mass Spectrometry (ICP-MS) for
inorganic components of the composite (e.g. Zr, Si, and Ti), and by liquid chromatography/
tandem MS (LC-MS/MS) for polymer degradation products. Micro- and nano-imaging analysis of
the dentin-adhesive-composite volumes (interfaces, pores, and cracks) should aid in clarification
of the sequence of events leading to clinical failure of dental composite restorations. It is
anticipated that significant differences will be observed between and among the bacteria
incubations versus the esterase enzyme in AS environments with respect to control specimens
(uncycled and aged 120 d in AS). It appears that behavior of dental composites subjected to
multiaxial loading in these two environments has not been reported on in the literature to date.
Dental composites are subjected to extreme chemical and mechanical conditions in the oral
environment, which contribute to the degradation and ultimate failure of the material in vivo.

Public health relevance
Narrative: This multidisciplinary project encompasses the disciplines of environmental microbiology, image analysis, and material testing to study the impact of aging on the interfaces and material properties of a dentin-adhesive-composite specimen. This interrelated-interfacial approach to dental composites degradation due to bacterial and mechanical insults will provide new information on the breakdown of restorative dental composite in the oral cavity using state-of-the-science imaging capabilities at the Advanced Photon Source at Argonne National Laboratory. This research will lead to improved understanding of the role of oral biofilms on dental composite polymer’s degradation and assist dentists and dental manufacturers in improving the material properties of dental composites as an esthetic and functional restorative material.